The sixth international workshop on metabolic imaging

Summary This application requests funds to defray travel and housing costs for students, postdocs and junior researchers attending the Sixth Annual Workshop on Metabolic Imaging. The conference will take place at the University of Pennsylvania from October 22-24, 2020. Because of its unique ability to interrogate their underlying cellular and molecular processes, metabolic imaging has the potential to help improve the diagnosis, management and treatment of numerous diseases, including many cancers. However, the fundamentally interdisciplinary nature of the field can be an obstacle to researchers' ability to share their findings efficiently and effectively. In 2006, our first metabolic imaging workshop aimed to address this problem directly by bringing together leading experts in the field from various departments and disciplines. Feedback from subsequent iterations of this meeting, which have consistently attempted to expand its interdisciplinary scope, have been uniformly positive. Prominent researchers in the fields of hyperpolarized MRI, PET, optical imaging and others will give invited talks on a diverse array of topics ranging from recent advances in hyperpolarization techniques and/or imaging technology to the clinical translation of now established techniques. We will also have 20-25 shorter presentations from students and postdoctoral researches, a poster session, and several panel discussions with question-and-answer sessions built-in. Full workshop proceedings will be webcast live and available internationally, and this video will be archived online for a period of 6 months after the meeting. Finally, we intend to publish highlights of this workshop in a special issue of NMR in Biomedicine.

Public health relevance
NARRATIVE This proposal requests funding to cover travel and lodging expenses for students and junior researchers attending the Sixth International Workshop on Metabolic Imaging, to be hosted at the University of Pennsylvania in Fall 2020. Given its unmatched ability to probe the cellular and molecular mechanism that underlie numerous disease processes, molecular imaging has a unique potential to help develop new techniques for both detection and treatment. This workshop will focus on the latest advances in molecular imaging, with an emphasis on expediting clinical translation.